Experimental Tobacco Marketplace: Forecasting the Impact of Novel Tax Proposals

The objective of this project is to forecast the impact of novel tobacco tax proposals in an evolving and complex tobacco marketplace, including how these proposals may interact with differences in income and educational level, and the introduction of low nicotine cigarettes (LNCs). Toward this end, we have developed the Experimental Tobacco Marketplace (ETM) to estimate, before implementation, the effects of potential policies on patterns of tobacco purchasing, including between-product substitution and poly-tobacco purchasing. The ETM places the mix of products, prices, and specific regulations under experimental control to provide estimates of policy impact under conditions that simulate “real-world” circumstances. Here we extend this method to examine the impact of four novel tax proposals that levy taxes across products based on either: (1) tobacco product parity, (2) nicotine content, (3) potential for harm, or (4) the Food and Drug Administration designation as a modified-risk tobacco product. To accomplish these objectives, we will leverage our extensive experience in the behavioral economics of tobacco purchasing, in general, and with our unique and innovative ETM, in particular, to forecast the impact of these tax proposals on differences in purchasing patterns. Specifically, Aim 1 will examine the effects of these four tax proposals on tobacco product purchasing in the ETM, including between-product substitution and poly-tobacco purchasing, in a laboratory-based sample of cigarette smokers. Aim 2 will examine the effects of these tax proposals on purchasing in a nationally representative sample of people with lower, medium and higher incomes and educational levels. Finally, Aim 3 will examine the impact of these tax proposals when LNCs are introduced to the market and when modeling a regulation that bans conventional cigarettes with higher nicotine content in a laboratory-based sample of cigarette smokers. Overall, this project is highly innovative and impactful because it prioritizes a clear translational path into public health policy and practice.

Public health relevance
Tobacco taxes are widely used and demonstrably effective in decreasing tobacco use and attendant diseases; however, the impact of taxes is complicated by an evolving and complex tobacco marketplace. This project will examine the effects of four novel tax proposals on tobacco product purchasing, including specific examinations of how these proposals interact with differences in income and educational level and regulations designed to limit the nicotine in conventional cigarettes. The findings of this project will inform tobacco regulation to improve overall public health.